EFFECT OF PERINATAL STRESS ON ADRENAL CATECHOLAMINES/HYPERGLYCEMIA

The purpose of this protocol is to detect and follow defective adrenal responsiveness. Mothers with increased risk factors are recruited. Catecholamines are measured in cord and postnatal blood, and after 18 months following administration of 2-deoxyglucose.